Developing resistance-breaking insecticides at mosquito muscarinic acetylcholine receptors to reduce malaria transmission

Project Summary/Abstract
Reducing vector populations will help decrease the global impact of mosquito-borne diseases. Over reliance on
insecticide classes repurposed from agriculture has culminated in widespread resistance, resulting in a critical
need to investigate physiological processes that can provide selective targets for insecticide development. Insect
muscarinic acetylcholine receptors (mAChRs) have been validated as an insecticide target, but no molecules
with this mode of action are currently used for pest control. The long-term goal of the proposed research is to
exploit pharmacological differences between insects and mammals to develop mAChR-selective insecticides to
be integrated into mosquito control programs. The overall objective of the proposed research is to investigate
the pharmacology and physiology of Anopheles gambiae mAChRs using chemical probes and novel nutrient
conjugates to enhance oral delivery of these toxicants. The central hypothesis of the proposed research is that
insect mAChR subtypes display unique pharmacology and play critical roles in the mosquito central nervous
system (CNS). The rationale for the proposed research is based on the global health burden that mosquitoes
impose, with a focus on the malarial vector Anopheles gambiae. Two specific aims will be performed to test the
central hypothesis. Specific Aim #1 will interrogate the pharmacology of An. gambiae mAChR subtypes using a
cholinergic chemical library with defined biological and pharmaceutical activity. Specific Aim #2 will focus on the
synthesis of a series of analogs of a lead molecule to probe the function of mosquito muscarinic receptor activity,
as well as absorption pathways for its dietary delivery. The proposed research is conceptually innovative as it is
a departure from the status quo by i) investigating the muscarinic system as an unexploited mode of action to
break insecticide resistance, and ii) leveraging midgut nutrient transporters to facilitate dietary uptake of pro-
insecticides. This project will provide significant advances to the fields of mosquito biology, as well as insecticide
toxicology and development.

Public health relevance
Project Narrative The proposed research is relevant to public health because it seeks to decrease the global health burden of Anopheles gambiae through enriching the insecticide pipeline by investigating an unexploited mode of action and enhance dietary uptake of proinsecticides. The proposed work is relevant to NIAID’s mission by increasing the fundamental knowledge of insecticide toxicology and vector biology to help control or prevent the transmission of vector-borne pathogens to humans.